Epicardial high-definition electrotherapy of AFib

Project Summary
Paroxysmal atrial fibrillation (AF) is expected to affect 16 million Americans in 2050. AF is a heavy
burden on the healthcare system. The current treatment strategies for AF include catheter
ablation, transthoracic cardioversion, and drug therapy. Currently, no method exists for painless
and rapid conversion of atrial fibrillation. This proposal features a novel epicardial high-
resolution organ conformal electronics low-energy atrial defibrillator for painless AF conversion.
In this project, a human-scale, fully implantable organ conformal device for high-definition
detection and therapy of AF will be developed. It will be tested and optimized on a large animal
model: a canine model of AF induced by high-rate atrial pacing. The endocardial coil-based multi-
pulse therapy (MPT) system previously developed in the Efimov laboratory was tested in
multicenter clinical trials for atrial fibrillation and ventricular tachycardia treatment. In this grant
proposal, the current resolution limitations of MPT will be overcome by (1) incorporating a high-
definition organ conformal array of electrodes to sense AF and delivery of MPT over a wide variety
of configurations and vectors; (2) deploying MPT on fully implantable battery-free high-definition
cardiac biointerface platform; (3) automatic detection of AF paroxysm; (4) machine learning
optimized delivery of low energy high-definition MPT to terminate AF paroxysm without delay to
prevent atrial pathological remodeling. In summary, rapid termination of AF paroxysm and
conversion to normal sinus rhythm will be achieved at painless energy levels by applying state-of-
the-art epicardial high-definition mapping and energy-efficient and optimized high-definition
MPT delivery.

Public health relevance
Project Narrative Atrial Fibrillation (AF) affects up to 6 million Americans today, and the current treatment options are limited to ablation or transthoracic defibrillation in hospital settings. In addition, both therapies are delayed after the onset of AF paroxysm, which leads to a progression of paroxysmal AF into more advanced and less treatable stages, such as sustained and permanent AF. The proposed project is based on recent advances in conformal battery- free bioelectronics and machine learning, which will serve as a novel platform for automatic detection and rapid pain-free termination of AF, preventing its worsening to a permanent AF stage.